Jumpstarting Culturally-informed Advance Care Planning with ANAI People in Primary Care

PROJECT SUMMARY
Chronic disease causes the most death and disability in the United States (US), and American Indian/Alaska
Native people (ANAIs) are more likely than people of all other races to die of heart disease, diabetes, chronic
lower respiratory disease, cirrhosis, stroke, pneumonia, kidney disease, and hypertension. Among ANAIs age
55 and older, 90% have at least one chronic condition, compared with 78% of their US peers. As the older ANAI
population rapidly increases, with higher rates of serious illness than the general population, there is an urgent
need for strategies to provide culturally tailored palliative and end-of-life care interventions for seriously ill ANAIs.
However, ANAIs are far less likely than their US peers to use palliative care, including advance care planning
(ACP), which involves discussing patient values and goals to align care with patient preferences. ACP leads to
better outcomes for patients, their families, and health systems, including decreased depression, anxiety, and
grief, fewer non-beneficial end-of-life treatments, and reduced cost. ACP is typically documented in advance
directives (ADs) that specify patient preferences for life-sustaining treatments and who can make medical
decisions on their behalf. Yet, less than a third of seriously ill US adults have ADs, and ANAIs age 55 and older
are only half as likely to have ADs as their White peers. Previous research suggests that ANAIs will engage in
ACP and complete ADs when given access to timely and culturally appropriate ACP conversations, but no ACP
communication interventions have been rigorously tested with ANAIs. Our team used community engagement
methods to culturally tailor an ACP communication intervention and pilot the tailored intervention—Jumpstart
ANAI—with 68 seriously ill adult ANAIs at Southcentral Foundation (SCF), a Tribal health system in Alaska. We
recruited 97% of the target sample (n=70) and retained >75% of patients at follow-up. We also found that 95%
of patients stated that Jumpstart ANAI helped them to have ACP conversations with their primary care providers.
This project expands upon a strong community-academic partnership to implement Jumpstart ANAI in
the Tribal health system and evaluate it using an innovative type 1 hybrid effectiveness-implementation
approach. Our specific aims are to: 1) Engage stakeholders to tailor an implementation plan for the Tribal health
system that integrates Jumpstart ANAI into routine primary care practice; 2) Conduct a cluster-randomized trial
with 40 primary care providers and 280 seriously ill ANAI patients to test the effectiveness of Jumpstart ANAI for
increasing ACP as compared to usual care; and 3) Conduct a rigorous mixed-methods process evaluation using
the Consolidated Framework for Implementation Research to assess barriers and facilitators to implementing
Jumpstart ANAI system-wide. Improving access to and delivery of culturally appropriate evidence-based ACP is
a high priority for Alaska’s Tribal health leaders and communities. By evaluating the effectiveness of a culturally
tailored ACP intervention and tailoring implementation of the intervention into routine care, this study will provide
critical evidence for improving palliative care and end-of-life care for seriously ill ANAI people and their families.

Public health relevance
PROJECT NARRATIVE The older Alaska Native/American Indian (ANAI) population is increasing at more than twice the rate of the general population and has higher rates of chronic illness. Yet, older ANAIs are only half as likely to have advance directives (AD), indicating a need for advance care planning (ACP) to ensure that care aligns with patients’ values and goals. This project will implement and evaluate a culturally tailored ACP intervention to increase ADs among seriously ill ANAI patients and provide evidence for improving palliative and end-of-life care delivery to this rapidly rising population of Americans.